Biostatistics

The TCI Biostatistics Shared Resource (BSR) collaborates with TCI members on designing laboratory experiments, population studies, and clinical trials. The BSR determines optimal experimental group sizes and drafts high-quality statistical analysis plans to ensure rigor and reproducibility. The BSR provides biostatisticians with expertise in comprehensive coverage of analytic methodologies, including software programming, table creation, and data visualization; staff translate these components into language understandable by the scientific community, along with supporting manuscript preparation and grant proposals. The BSR contributes extensive review, monitoring, and oversight for investigator-initiated clinical trials in collaboration with the Clinical Trials Office, Protocol Review and Monitoring Committee, and Data and Safety Monitoring Committees. Training on all quantitative data science disciplines is available through seminars, walk-in clinics, and workshops. The Specific Aims of this Shared Resource are to: (1) Support the evolving biostatistical requirements of TCI investigators; (2) Provide review, monitoring, and oversight for investigator-initiated clinical trials.